MONOCYTE DIFFERENTIATION-- ROLE OF TYROSINE PHOSPHORYLATION VIA CSF-1 RECEPTOR

The mouse hematopoietic cell ine, 32D, was transfected with c-fms, which enclodes for the CSF-1 receptor, a tyrosine kinase (TK). In the absence of CSF-1, transfected cells show moderate levels of arachidonic acid (A.A.) release and produce a substantial amount of prostaglandin E2 (PGE2) in comparison with the original cell line. Exposure of transfected cells to CSF-1, while inducing a substantial increase in arachidonate release, nevertheless resulted in inhibition of PGE2 production. Addition of ST638, a tyrosine kinase inhibitor, to cells transfected with c-fms in the absense of CSF-1 inhibited PGE2 within 10 to 60 minutes. Its addtion to the same cells in the presence of CSF-1 receptor may regulate cyclooxygenase activity. The different effect of CSF-1 receptor of PGE2 production in the presence or absence of CSF-1 and the opposite effect of a tyrosine kinase inhibitor on PGE2 suggest that both the receptor alone or the receptor-ligand complex transduce on active, but different, signal through tyrosine phosphorylation.